Neural mechanisms for coordinating the sampling of environmental information and internally stored information

PROJECT SUMMARY
Daily activities, such as driving a car, require selective processing of external information that is present in the
environment (i.e., during selective attention) and internal information that is stored within the mind (i.e., during
working memory). Previous research has shown that the sampling of external information and the maintenance
and sampling of internal information are associated with shared neural resources in frontal, parietal, and
sensory cortices. Shared neural resources might lead to competitive interactions between these processes
during tasks that require both external and internal sampling. Here, we will investigate the neural mechanisms
through which the brain coordinates the sampling of external and internal information to avoid competitive
interference. There are two specific aims. In Aim 1, we will test whether the same neurons or different neurons
represent and sample external and internal information under different task conditions. We will intracranially
record from macaque frontal, parietal, and sensory cortices while the animals complete a task that requires (i)
only external sampling, (ii) only internal sampling, or (iii) both external and internal sampling. We predict that
during trials that require both external and internal sampling (i.e., during dual-task trials), there will be a shift
toward functional segregation, with neurons (and perhaps brain regions) specializing for external or internal
sampling. In Aim 2, we will use the same data to test whether the competition between external and internal
sampling—for shared neural resources—leads to the separation of functionally specific neural activity over
time. That is, we will test whether external and internal sampling are temporally coordinated on a sub-second
timescale, consistent with previous evidence that competing neural processes can be coordinated by theta-
rhythmic neural activity (3–8 Hz). Our findings will provide critical insight into how the brain flexibly
accomplishes selective processing during tasks that require both environmental information and internally
stored information. It will also provide cross-species translation between humans and macaques, given that we
are building on a human EEG project that used the same behavioral task. Finally, the proposed experiments
will address several ongoing debates in cognitive neuroscience, including (i) the extent to which selective
attention and working memory utilize a shared sampling process, (ii) whether higher order (i.e., frontal and
parietal) cortices engage visual cortex to help represent to-be-remembered information (i.e., during working
memory), and (iii) whether the theta-rhythmic coordination of neural activity provides a general mechanism for
avoiding functional conflicts during cognitive processes. Dysfunctions of attention and working memory are
markers of common disorders, such as attention-deficit/hyperactivity disorder (ADHD). By investigating how
the brain typically balances the sampling of information from the environment and internal memory stores, we
will provide important insights to help the development of effective treatments for these disorders.

Public health relevance
PROJECT NARRATIVE: Everyday activities, such as driving a car, require the selective processing of information from both the external environment and internal memory stores. The proposed research will investigate the neural basis of how the brain balances such external and internal sampling, focusing on (i) whether and how the neural basis of these processes shifts during dual tasks (i.e., tasks that require both external and internal sampling) and (ii) how these processes are coordinated over time. Understanding how the brain flexibly coordinates the sampling of external and internal information is a critical step toward developing effective treatments for disorders marked by abnormalities in cognitive flexibility, such as attention- deficit/hyperactivity disorder (ADHD) and obsessive-compulsive disorder (OCD).